Shared Resource Management

The overarching goal of the Winship shared resources (SRs) is to provide comprehensive research services and
expertise to meet the present and future needs of Winship members across all four scientific research programs.
Winship SRs have grown to nine `full' (six in the previous submission) and two `developing' SRs (dSR) that are
aligned with the research programs through effective shared resource management (SRM). Two SRs (Data SR
and Dissemination SR) transitioned from `developing' to `full' SRs and Flow SR launched during the reporting
period to meet program member needs. These nine SRs highlight the growth in the SR service portfolio which
stems from increased SR usage, needs-assessment of Winship researchers, and opportunistic partnerships
across the university to expand services and align with the Winship strategic plan. SRM has three overarching
aims that seek to provide cutting-edge and cost-effective SRs, deploy effective infrastructure and governance,
and monitor the future scientific needs to guide the launch of new services and technologies. Winship SRs are
integral to multiple team science grants, publications, major strategic research initiatives and educational events.
Annual Winship SR usage by members increased 25% from 85 members in CY2016 to 106 members in CY2021
with a total SR usage of 149 unique Winship members from all programs during this time period. SR services
have supported 539 peer-reviewed cancer-related publications (22% in journals with impact factor >10) from
Winship members and 225 peer-reviewed grants from CY2016 to CY2021. Winship increased the space
allocated to shared resources by >60%, with a total of 28,607 gross square feet (gsf) (up from 17,562 gsf in
2016), including a $5 million investment in the renovation of a newly renovated 8,800 gsf SR Hub. In total,
Winship has invested $20.9 million in shared resources since 2017 resulting in the purchase of new equipment,
newly renovated space, and hiring additional personnel. The future plans for SRM align with the Winship strategic
plan and include capital and personnel investments in the developing Immune dSR and Cell Therapy dSR,
growth of services/technologies in existing SRs, expanded Winship support for extramural SR grant applications,
and expanded educational initiatives.